Overcoming Barriers of Virotherapy by Next-Generation oHSV Expressing E-Cadherin

Despite research efforts over the past two decades, glioblastoma (GBM) is still a devastating, deadly cancer
with a median overall survival of less than 15 months. Oncolytic virotherapy is a promising approach for GBM
treatment because it not only involves direct lysis of tumor cells and spares normal cells but also boosts
immune responses to tumor cells. However, early clearance of oncolytic viruses by innate immune responses,
poor virus propagation in tumor cells, and insufficient viral entry and/or spread present barriers that limit the
efficacy of oncolytic virotherapy. In this application, we generated oncolytic herpes simplex virus 1 (oHSV)
carrying a “don't eat me signal”, i.e., being engineered to express a ligand, E-cadherin, of the inhibitory
receptor of natural killer (NK) cells, KLRG1. This next-generation oHSV carrying E-cadherin (named E-oHSV)
reduces the deleterious NK-mediated clearance of oHSV. Importantly, unlike the drugs that we and others
previously used to suppress oncolytic virus clearance by innate immune responses, the novel E-oHSV that we
generated should not have an immunosuppressive effect systemically or even in the tumor (GBM)
microenvironment. That is, E-oHSV only reduces activation of NK cells that bind to or attack E-oHSV-infected
cells in the tumor microenvironment, while the remaining NK cells will maintain their potency against GBM
cells. E-oHSV also showed enhanced viral production likely by increasing cell-to-cell fusion between virus-
infected and uninfected cells. GBM cells do not have endogenous E-cadherin expression; however,
interestingly, we found that E-cadherin is not only highly expressed on the surface of E-oHSV-infected cells but
also loaded on free viral particles, the latter of which facilitates viral entry and/or spread in solid tumors. These
improvements on oncolytic viruses led to significantly enhanced survival of mice bearing patient-derived GBM
cells and also prolonged animal survival in an orthotopic, immunocompetent GBM model. In this application,
we propose to mechanistically characterize this E-oHSV and to strengthen our hypothesis that a next-
generation oHSV expressing E-cadherin, E-oHSV, plays multiple roles to overcome the barriers of
oncolytic virotherapy and thus has a superior efficacy for GBM treatment. Three aims have been
proposed: Aim 1 is to explore the mechanisms by which innate immune responses to E-oHSV are inhibited.
Aim 2 is to explore the mechanisms by which E-oHSV enhances cell-to-cell infection, viral binding, and thus viral
spread and distinguish them from the NK inhibition mechanism. Aim 3 is to investigate in vivo mechanisms,
efficacy, and potential toxicity of E-oHSV for GBM treatment. Collectively, our study will not only address
fundamental questions on NK cell and OV biology, but will also develop novel therapeutics for GBM treatment.
It may also provide a platform to enhance efficacy of non-HSV oncolytic viruses.

Public health relevance
Despite surgery, chemotherapy, and radiotherapy, glioblastoma (GBM) remains an incurable and devastating cancer with a median survival of approximately 15 months following diagnosis. The efficacy of oncolytic virotherapy is a promising treatment for GBM, but oncolytic viruses are rapidly cleared by host immunity, and the viruses have poor reproduction and limited spread in solid tumors. In this application, we generated a novel next-generation oncolytic herpes simplex virus 1 to overcome these barriers by inhibiting clearance from inmate immune cells and enhancing viral spread in tumors, leading to a superior efficacy for GBM treatment.